EPIDEMIOLOGY OF SHIGELLA INFECTION IN CHILDREN

This project is to evaluate the safety and immunogenicity of its investigational Shigella conjugate vaccines in an area where shigellosis is common (Phase 2). If Phase 2 study is successful NICHD will evaluate the efficacy of these vaccines (Phase 3) in prevention of dysentry due to S. dysenterlae type 1 and S. flexneri in children.